Realizing Accelerated Progress, Investigation, Implementation, and Dissemination in Learning Health Systems (RAPID-LHS) Center

Realizing Accelerated Progress, Investigation, Implementation, and Dissemination
in Learning Health Systems (RAPID-LHS)
Major gaps exist between the generation of clinical evidence, widespread implementation of proven
interventions, and formulation of informed policy. The learning health system (LHS) aims “to generate and
apply the best evidence for the collaborative healthcare choices of each patient and provider; to drive the
process of discovery as a natural outgrowth of patient care; and to ensure innovation, quality, safety, and value
in healthcare.” Vanderbilt will formally train a cadre of RAPID-LHS scientists well versed in the best methods
for integrating patient-centered outcomes, evidence implementation, and evaluation of health policies within
the LHS. We propose to establish the Realizing Accelerated Progress, Investigation, Implementation, and
Dissemination in Learning Health Systems (RAPID-LHS) Center to train faculty to conduct high-impact
research that is embedded in the LHS. In cross-training scientists and embedding them in the health system,
we will draw together scientists and mentors across disciplines and model the team science integral to LHS.
We will provide forums that demonstrate the intellectual productivity and practical benefits of interdisciplinary
research in advancing human health. We endorse team approaches to filling gaps in knowledge and
translating knowledge into application. A diverse pool of scientists from internal (Vanderbilt University
Medical Center) and partner health systems (Meharry Medical College, the VA Quality Scholars Program,
Vanderbilt University, Vanderbilt Health Affiliated Network, Safety Net Clinics, and the STAR Clinical Research
network) is available. Career milestones for scientists will include impact on health equity, population health
and patient health, publications and grants. LHS lessons learned during project development will advance LHS
science.
All RAPID-LHS scientists will conduct embedded projects in conjunction with Research and Data Analysis
Core (RDAC), focusing on 1) patient-centered outcomes research, 2) dissemination and implementation
science, 3) health policy/public health, 4) stakeholder engagement and health equity, and 5) methods
advancement. Each embedded project will begin with in-depth feedback from a Community Engagement
Studio and LHS Platform Studio, which will follow a structured process to ensure that the clinical question is
important and that the research is needed. All scientists will then meet with RDAC mentors to determine their
needs and prepare a structured workplan. The research will use a health equity lens to prevent unintended
consequences of interventions in the health system. Each scientist will engage in integrated didactic and
experiential training through the Research Education Core. The RAPID-LHS scientists’ progress will be
facilitated by VUMC’s rich environment for training in LHS and supporting projects with real-world impact.

Public health relevance
The learning health system is designed to “to generate and apply the best evidence for the collaborative healthcare choices of each patient and provider; to drive the process of discovery as a natural outgrowth of patient care; and to ensure innovation, quality, safety, and value in healthcare.” Vanderbilt is committed to establishing the Realizing Accelerated Progress, Investigation, Implementation, and Dissemination in Learning Health Systems (RAPID-LHS) Center to develop a cadre of scientists formally trained and well versed in the best methods for engaging and improving the learning health system. The RAPID-LHS Center will train future scientists and provide support in the following areas of strength: 1) patient-centered outcomes research; 2) dissemination and implementation science; 3) health policy/public health; 4) stakeholder engagement, community health, and health equity; 5) methods advancement.